Novel Sequencing Based Diagnostics for Leukemia in Low Resource Settings

Project Summary
Most cases of cancer worldwide are diagnosed in low and middle income countries (LMIC), where access to
diagnostic technologies is limited and survival rates are low. Diagnostic resources such as flow cytometry,
cytogenetics, and molecular panels are inconsistently accessible or wholly unavailable. Specifically, pathologists
and clinicians cannot reliably differentiate lymphoid- from myeloid leukemia, or stratify biologic risk, leading to
inaccurate or incomplete diagnosis and inappropriate treatment selection, which contributes to lower survival
rates. Through development of new technical and computational approaches and feasibility testing in Malawi,
we propose to advance a novel cost-effective sequencing approach to improve comprehensive leukemia
diagnosis in LMICs.
Our approach, using unbiased Oxford Nanopore RNA sequencing, requires low capital and per specimen costs.
We have performed nanopore RNA sequencing for gene expression analysis on 124 cases of acute leukemia,
demonstrating high quality RNA transcripts across a range of input conditions. We developed a pipeline that
classifies leukemia lineage and core genomic subtypes. We hypothesize that locally implemented genomic
sequencing, with minimal capital investment and limited training, accompanied by appropriate computational
algorithms, can overcome diagnostic deficiencies for acute leukemia.
In the proposed project, we will demonstrate feasibility of unbiased nanopore RNA sequencing as a diagnostic
tool for acute leukemia in a low resource setting through technical and computational implementation. In Malawi,
we will train laboratory personal to generate nanopore RNA sequencing from sixty diagnostic acute leukemia
specimens. We will develop protocols and regulatory approvals for deposition of data into a secure cloud base
system for analysis, which will allow iterative improvement of classification algorithms through ongoing collection
of long-read RNA sequencing data. In parallel, we will significantly expand our cohort of nanopore RNA
sequencing cases at the University of North Carolina, improving computational algorithms to classify genomic
subtypes based upon nanopore gene expression profiling, validated with pathologic diagnosis and short read
(eg. Illumina) sequencing data. We will develop computational pipelines and explore sequencing depth required
using unbiased nanopore RNA sequencing to directly identify genomic alterations, such as fusion transcripts,
aneuploidy, and FLT3 internal tandem duplications, which could allow for precision medicine approaches.
Throughout this research period, we will plan for a future implementation study with a multidisciplinary group of
domestic and international collaborators with expertise in clinical oncology, pathology, genomics, health
economics, and implementation. Our innovative diagnostic approach could provide lineage and genotype
leukemia classification on a single cost-effective platform, leading to transformational change in the diagnostic
accuracy and subsequent clinical management of patients with acute leukemia in LMICs.

Public health relevance
Project Narrative Most cases of cancer worldwide are diagnosed in low resource settings, where centers lack access to diagnostics technologies, leading to inaccurate or incomplete diagnosis and inappropriate treatment selection, and contributing to lower survival rates. In response to this deficiency, we have discovered that low-cost, shallow- depth, long-read Oxford Nanopore RNA sequencing can accurately classify acute leukemia lineage and genomic subtypes. We will perform technical and computational validation in a low resource setting, enhance our computational pipelines for gene expression based subtype classification, and develop computational approaches to detect fusion transcripts and inferred aneuploidy, resulting in a subtype agnostic, cost-effective sequencing solution to specific global challenges in cancer diagnostics.